Longitudinal Assessment of Brain Structure and Function in Juvenile Onset Huntington's Disease

PROJECT SUMMARY:
Huntington's disease (HD) is a genetic neurodegenerative disorder caused by an abnormal expansion of a
trinucleotide CAG repeat region of the huntingtin gene (HTT). The majority of patients with HD do not present
with symptoms until the age of 40-50 years old, on average, which is referred to as Adult-Onset HD (AOHD).
A much smaller percentage of patients with HD receive a motor diagnosis prior to the age of 21, which is
referred to as Juvenile-Onset HD (JOHD). Although patients with JOHD have the same core triad of
cognitive, behavior, and motor symptoms, there are unique clinical characteristics that are distinct from AOHD.
Specifically, patients with JOHD have less chorea compared to patients with AOHD, often presenting with
rigidity and bradykinesia. However due to the rarity, there is a paucity of data regarding the symptom
characterization, the neurobiology, and the progression of JOHD. Large-scale observational studies have been
performed in AOHD, which have broadened our understanding of HD and opened the doors for the
development and conduct of clinical trials. Patients with JOHD have been excluded from clinical trials, leaving
patients and their families feeling hopeless and abandoned by the scientific community. Large-scale,
longitudinal studies in patients with JOHD are critical to bettering our understanding of this devastating
disease and providing hope to patients who have felt left behind as therapeutic strategies advance in AOHD.
We propose here the first ever comprehensive, clinical and neuroimaging study of JOHD. At the University of
Iowa, we have performed a pilot longitudinal clinical and neuroimaging study to understand the progression of
JOHD. We compared JOHD subjects to age and sex matched controls. In addition, we compared rate of
change over time to AOHD subjects from the large PREDICT-HD study. Results from our pilot are striking:
First, standard measures of cognition, and standard measures of motor dysfunction (United Huntington's
Disease Rating Scale or UHDRS) show significant decline over time, supporting the notion that these
measures accurately track disease. This includes a `hypokinesis' sub-score of the UDRS that is particularly
relevant for JOHD subjects. Second, patients with JOHD demonstrate impressive striatal atrophy even in very
early stages after motor onset. However, the striatum and other subcortical structures continue to degenerate,
suggesting that they can be used for quantitative measures of disease progression. Third, striatal volume is
closely related to clinical symptoms, showing strong correlations to the UHDRS, and cognitive symptoms are
associated with thalamus volume. Fourth, in all of these observations, the rate of progression is faster
and less variable in JOHD compared to patients with AOHD. These findings suggest JOHD may be a
superior group for clinical trials.

Public health relevance
PROJECT NARRATIVE: This study is a resubmission of a competitive revision of the parent study, Growth and Development of the Striatum in Huntington's Disease (HD). The parent study is a five-site study evaluating subjects age 6-30 years of age who are at risk for HD, meaning they have a parent with HD, so the current proposal seeks to `piggy-back' the assessment of Juvenile Onset Huntington's Disease (JOHD) onto the infrastructure of the parent study. JOHD subjects are understudied and the primary aim is to conduct the first ever prospective longitudinal study to evaluate symptom phenomenology and disease course.